Systematic Testing of a TGFβ Targeted Theranostic in Preclinical Cancer

ABSTRACT
Radiopharmaceutical therapy (RPT) has received approval for the treatment of thyroid (131I), neuroendocrine
(177Lu-Dotatate), neuroblastoma (131I-MIBG), lymphomas (90Y-antiCD20, 131I-anti-CD20), and prostate cancers
(223Ra, 177Lu-PSMA). The efficacy of targeted RPT for these cancers has motivated RPT approaches that
broaden its use in other patient populations. A tumor-agnostic theranostic in which the patient selection is based
on validated target by positron emission tomography (PET) would be highly desirable. Transforming growth
factor β (TGFβ) is controlled by a highly regulated process of extracellular activation, which is tightly controlled
in normal tissue and highly dysregulated in cancer, thus providing a favorable tumor to tissue differential that
can be exploited for the delivery of a therapeutic isotope. We propose that TGFβ activity is a promising target
for a tumor-agnostic theranostic. We demonstrated specific detection of TGFβ activation in breast, brain, and
lung cancer modus using 89Zr-labeled TGFβ neutralizing antibody for PET imaging. Here, we aim to leverage
our deep knowledge of TGFβ biology and the clinical benefit of RPT to understand the biological basis for TGFβ-
targeted RPT efficacy. Our multi-principal investigator team of a radiobiologist, radiochemist, and imaging
physicist will collaborate to label a clinically validated human neutralizing TGFβ antibody with an imaging isotope,
89Zr, and a therapeutic isotope, 177Lu, to evaluate pharmacokinetics and dosimetry in five mouse models that
differ in TGFβ activity, tissue origin, and radiosensitivity. Our goal is to assess the relative biological effectiveness
of TGFβ RPT by comparing the delivered dose as a function of the level of TGFβ activation, TME composition,
radiosensitivity and immunity. Aim 1 will radiolabel fresolimumab with 89Zr for PET imaging to ascertain TGFβ
activity differentials in vivo and with 177Lu to assess dose delivered to 5 isogenic cancer models in which
TGFβ activity is engineered or induced to be high versus low. Aim 2 will test TGFβ RPT compare cellular
mechanisms of radiation response between isogenic pairs and across mouse models to establish the basis for
its relative biological effectiveness for tumor control. Our highly innovative project will employ diverse preclinical
breast, brain, and lung cancer models, measure key cellular mechanisms of radiation response and ascertain
integrated total dose to delineate the interaction between dose and biological mechanisms as determinants of
TGFβ RPT response. The resulting foundational data on tumor response and cellular radiobiology as a function
of the delivered dose will also illuminate how RPT dynamically impacts cancer biology processes, which is a
primary goal of STRIPE (PAR-22-139).

Public health relevance
NARRATIVE The clear benefit of RPT in thyroid, prostate and neuroendocrine cancers might be expanded across cancers by using a tumor agnostic radiopharmaceutical. The goal of this proposal is to test a theranostic targeted to dysregulated TGFβ activity in multiple cancer models, and to correlate overall tumor response and the biological basis for efficacy, after correcting for integrated tumor dose, with known microenvironment, cellular and immune mechanisms that determine radiation sensitivity.